Longitudinal Analysis of Biomedical Imaging Data

DESCRIPTION (provided by applicant): Many large-scale longitudinal imaging studies have been or are being widely conducted to better understand the progress of neurodegenerative and neuropsychiatric disorders or the normal brain development. Compared to cross-sectional imaging studies, the longitudinal imaging studies can identify subtle anatomical and functional changes and the causal role of time-dependent covariate (e.g., exposure) in disease process. However, analysis of longitudinal imaging data has been hindered by the lack of advanced image processing and statistical tools for analyzing complex and correlated imaging data along with behavioral and clinical data. Relatively, cross-sectional image processing and statistical tools have been developed and used, but they are in general not optimal in power. In response to PAR-06-411, the primary goal of this project is to develop new statistical tools and to evaluate these statistical tools and 4D image processing for analysis of imaging data, in combination with behavioral and clinical information obtained from longitudinal studies. As these tools are developed, they will be evaluated and refined through extensive Monte Carlo simulations and data analysis. Also, the efficacy of the tools developed under this grant will be tested by both simulated longitudinal datasets and the ADNI (Alzheimer's Disease Neuroimaging Initiative) dataset for early detection of Alzheimer's Disease (AD), respectively. Moreover, the companion software for all developed statistical tools, once validated, will be disseminated to imaging researchers through http://www.nitrc.org/, as we did for our brain image registration algorithm called HAMMER. This longitudinal analysis software will provide much needed imaging tools for analyzing complex, correlated imaging data in biomedical, behavioral, and social sciences. Thus, it is applicable to a variety of longitudinal neuroimaging studies, e.g., on major neurodegenerative diseases, neuropsychiatric disorders, substance use disorders, and brain development. PUBLIC HEALTH RELEVANCE: The project proposes to analyze imaging, behavioral, and clinical data from one large neuroimaging study on Alzheimer's diseases. New statistical methods are developed and applied to detect morphological differences of cortical and subcortical structures across time between Alzheimer patients and healthy subjects.

Public health relevance
Project Narrative The project proposes to analyze imaging, behavioral, and clinical data from one large neuroimaging study on Alzheimer's diseases. New statistical methods are developed and applied to detect morphological differences of cortical and subcortical structures across time between Alzheimer patients and healthy subjects.